DIURNAL CHANGE IN SERUM DIGOXIN LEVELS IN PTS. WITH ATRIAL FIBRILLATION

The purpose of this study was to determine whether there were significant nocturnal changes in digitalis concentration, and to see if these changes were associated with changes in plasma volume.